Mechanisms and Functional Consequences of Signaling Protein Organization at Membranes

My lab seeks to understand the cell biophysical mechanisms regulating transmembrane signal transduction, i.e.
signal transfer from ligands to receptors to downstream effectors. There is mounting evidence that cell surface
receptors and associated proteins exhibit a high degree of dynamic organization at the plasma membrane (PM),
which is critical for their ligand binding and signaling. However, many fundamental questions remain
unanswered. Toward filling this gap in our knowledge, my lab will pursue two research directions over the next
five years. The first direction will investigate how focal adhesions, the actin cortex, and interactions with integrins
regulate the spatiotemporal organization and signaling of the endothelial cell receptor VEGFR2. VEGFR2 is the
main promoter of angiogenesis (the formation of new blood vessels from existing vessels) in both normal
physiology and disease. Thus there is great interest and need to understand the mechanisms that regulate its
signaling. These studies will reveal mechanisms that underlie the activation of multiple pathways downstream of
VEFR2, and that underlie the integration of multiple external signals at the level of the PM. As VEGFR2 belongs
to the large family of receptor tyrosine kinases, our studies are expected to reveal general principles of the
regulation and signaling of this important family of receptors. The second direction will focus on the novel
organizational principle of liquid-liquid phase separation (LLPS) for proteins at the PM, using the transmembrane
protein LAT as a model system. LAT is critical for the activation and immune function of T cells upon encountering
an antigen presenting cell. Recent in vitro reconstitution work suggests that signaling clusters composed of LAT
and its downstream effectors are formed through LLPS. The cellular environment is however much more
complex than an in vitro reconstituted system. Thus we will investigate to what extent LAT microclusters at the
PM of T cells are formed through LLPS, and the mechanisms that regulate LAT cluster composition. These
studies will shed light on the role of LLPS for protein organization within the cellular environment in general. Both
research directions – by their very nature – require probing molecular activities with high specificity and resolution
in their native cellular environment. To achieve this, we will develop integrative approaches based on live-cell
single-molecule, super-resolution and activity biosensor imaging, combined with cutting-edge mathematical and
statistical analysis tools to extract quantitative information from the experiments and to multiplex the
complementary information that the different imaging modalities provide. These analytical tools will be critical for
our studies because single-cell and single-molecule microscopy often reveal molecular and cellular
heterogeneity that is difficult to digest without such tools. We expect our novel analytical tools to be broadly
applicable to other systems studied via similar experimental approaches. The knowledge gained from our studies
will provide the building blocks for deepening our understanding of cell signaling from the single-molecule level
to the systems level.

Public health relevance
There is mounting evidence that proteins at the cell membrane, which allow cells to sense and respond to the external environment, are highly organized. The goal of the proposed studies is to investigate the nature of this organization, how it comes about, and how it affects the proteins’ functions, focusing on processes that regulate blood vessel formation and immune cell function. This will be achieved by developing innovative live-cell imaging and computational image and data analysis approaches to quantitatively probe molecules in their native cellular environment and dissect their complex behaviors and interrelationships.